Rare Bronchiectatic Diseases Consortium

ABSTRACT
Four rare bronchiectatic diseases (RBDs), including primary ciliary dyskinesia, alpha-1 antitrypsin, humoral
immune deficiency, and STAT3-HIES, manifest bronchiectasis (BE) as a severe pulmonary complication. BE,
defined by airways dilation/ectasia on chest CT imaging, is associated with cough, sputum production, acute
exacerbations (AE), loss of lung function, and increased mortality. Progress in therapeutics for the most prevalent
form of BE (non-cystic fibrosis bronchiectasis, NCFB), and by implication, the 4 RBDs selected for study, has
been slow. Part of this “tardiness” in therapeutics development has been the incomplete nature of the “Vicious
Vortex” hypothesis, a paradigm for investigating BE pathogenesis which we posit is missing key elements that
initiate and perpetuate the “Vortex”. Presently, there is an urgent need to accelerate BE therapeutics
development. Key missing elements include data describing the clinical trajectory of each RBD and disease-
informative BE biomarkers. Using new insights and biomarkers derived from a novel “Vicious Vortex 2.0”
hypothesis, combined with new observational studies, this U54 proposes to fill in the gaps to accelerate BE drug
discovery, build a pipeline of rare disease investigators, and conduct ancillary studies, some in partnership with
industry. This work will be conducted in partnership with the Patient Advocacy Groups (PAGs) associated with
the 4 RBDs. To accomplish these goals, we propose 2 projects: Project 1, “Longitudinal Study of Clinical
Outcome Measures and Biomarkers in Rare Bronchiectatic Diseases” (K. Olivier, MD, MPH, PI), will define
clinical trajectories of the 4 RBDs over a 3-year longitudinal observational period as quantitated by pulmonary
function tests, patient-reported outcomes, AEs, and novel CT analyses. Ancillary goals are to collect sputum,
BAL, oral, and blood samples for biomarker testing. Emphasis for biomarker development is focused on novel
mucus parameters, anaerobic microbiomes, and metabolomics. Airway epithelial and microbiome samples will
be collected for collaborative studies with Project 2. Project 2, “Rare Bronchiectatic Disease Biomarkers and
Novel Treatable Traits” (R. Boucher, MD, PI), provides complementary laboratory-based studies of patient-
derived materials obtained from Project 1, supplemented by studies of excised lung specimens from the 4 RBDs.
Goals are to utilize high-content RNA/protein technologies, coupled with studies of cultured airway epithelia from
RBD patients designed to measure responses to BE provocants (aspiration, viral infections, and oral microbiome
challenge) to identify/validate novel biomarkers and treatable traits. Cores focused on Career Enhancement,
Pilot and Feasibility Study Development, and Administration have been assembled to achieve our goals.
Deliverables will be: 1) high-quality/high-content clinical data describing the 3-year clinical trajectory of the 4
RBDs, coupled to identification/validation of a suite of novel biomarkers vetted by in vitro and in vivo studies; 2)
identification of novel RBD common and specific “treatable traits”; 3) training the next generation of rare disease
investigators; and 4) conducting ancillary studies that will lead to clinical trials.

Public health relevance
PROJECT NARRATIVE The Rare Bronchiectatic Diseases Consortium will study four rare diseases, primary ciliary dyskinesia, alpha-1 antitrypsin deficiency, humoral immunodeficiencies, and STAT3-hyper IgE syndrome, which are all associated with respiratory disease manifesting in bronchiectasis, a progressive inflammatory condition of the airways associated with chronic/recurring infection. In partnership with Patient Advocacy Groups and the Rare Diseases Clinical Research Network, we plan to advance awareness of these rare conditions, improve our understanding of bronchiectasis, collect clinical and endpoint data critical for clinical trials, and identify therapeutic targets. We anticipate that these efforts will transform our clinical practice and improve outcomes for patients affected by these diseases leading to bronchiectasis.